Uncovering Novel Protease Substrates and Inhibitors to Modulate Pyroptosis and Prevent Cancer Progression

Project Summary
Proteases are pivotal players in cellular biology, acting as both guardians of homeostasis and mediators of stress
responses. Their roles are indispensable to cellular function, ranging from protein turnover and immune
responses to mitochondrial maintenance and beyond. Understanding the precise regulatory mechanisms of
proteases provides unique opportunities to identify and exploit vulnerabilities in cancer progression.
Aim 1 (F99 phase) focuses on identifying the physiologically relevant DPP9 inhibitor. DPP9 is a protease, which
regulates inflammasomes—multiprotein complexes that detect danger signals and trigger pyroptosis, a lytic form
of cell death. Under normal conditions, DPP9 represses the NLRP1 and CARD8 inflammasomes. Importantly,
synthetic DPP9 inhibitors have been shown to activate these inflammasomes, triggering pyroptosis. However,
the identity of an endogenous inhibitor remains elusive. Discovering this physiologically relevant inhibitor is
crucial, as it will reveal the evolutionarily conserved danger signals that the NLRP1 and CARD8 inflammasomes
evolved to sense, opening novel avenues for modulating inflammasome activation—a promising strategy for
cancer immunotherapy.
Preliminary data indicate that DPP9 interacts with the redox sensor KEAP1 through an ESGE motif, leading to
mutual inhibition of both proteins. This interaction suppresses DPP9's catalytic activity and inhibits KEAP1's
ability to sequester NRF2, stabilizing NRF2 and activating the antioxidant response system. Intriguingly, in
DPP9’s native state, the ESGE motif is structurally incompatible with KEAP1 binding, suggesting that a
conformational change in DPP9 is required for this interaction to occur. In Aim 1, this proposal seeks to (1)
identify the stimulus that drives this conformational change, enabling KEAP1 binding and mutual inhibition, and
(2) unbiasedly identify genetic regulators of DPP9 activity. Together, these studies aim to uncover the
endogenous inhibitor of DPP9, define its role in inflammasome activation, and ultimately harness pyroptosis as
a targeted cancer therapy.
Aim 2 (K00 phase) focuses on identifying mitochondrial proteases critical for maintaining mitochondrial function
under the metabolic and oxidative stresses of the tumor microenvironment. Unlike the cytosol, mitochondria lack
a proteasomal degradation system and depend on proteases to prevent the accumulation of misfolded or
damaged proteins, ensuring cellular adaptation and survival. In this Aim we will employ unbiased proteomics
and CRISPR-based approaches to identify mitochondrial proteases and their cognate substrates that are
essential for cancer cell survival. These studies will reveal how mitochondrial proteostasis enables cancer cell
resilience and uncover therapeutic opportunities to selectively disrupt these processes, compromising cancer
cell survival while sparing normal cells.

Public health relevance
Project Narrative This research proposal aims to elucidate the role of proteases in key cellular processes critical to cancer progression and therapy. By uncovering the endogenous inhibitor of the inflammasome-regulating protease DPP9 and identifying mitochondrial proteases critical for cancer cell survival, this study seeks to develop novel strategies to enhance cancer immunotherapy through pyroptosis induction and to disrupt tumor metabolism for targeted treatments. The anticipated findings have the potential to pave the way for innovative cancer therapies.